Profiling the Fluid Assisted Dissemination of Pre-malignant cells in Fallopian Tubes

PROJECT SUMMARY
The high mortality rate in ovarian cancers is explained in part, by late-stage clinical diagnosis where
intraperitoneal tumor burden is already prevalent and widespread. Shedding and implantation of transformed
secretory cells, originating from the fallopian tube, is considered one of the main initiators of ovarian cancer.
During the early stages of this disease, secretory fallopian tube cells gain mutations that support migration
(against the direction of fluid flow) to the ends of the fallopian tubes (fimbriae). At the fimbriae, the mutated
fallopian tube cells form small early precursor lesions. Both the ovaries and fallopian tubes are suspended within
the abdominal cavity, where the environment further exposes early precursor tumor cells to dynamic shear
stresses. We therefore hypothesize that the fluidic shear stress stimulates the early precursor lesions in the
fallopian tubes and modulates their dissemination to the ovary and peritoneal organs.
In order to test this hypothesis, we will utilize microfluidic devices and bioreactors to circulate cell growth medium
around transformed human and mouse fallopian tube cell lines that are supported on an agarose-collagen,
polysaccharide-protein scaffold. Human immortalized fallopian tube cells with varying degrees of genetic
mutation will be probed for changes in cell replication, migration, invasion, cell death, and genetic variation after
stimulation of shear stress. Our preliminary data suggests a robust increase in the expression of GPRC5A in
fallopian tube secretory epithelial cells (FTSEC) under shear stress stimulation. Therefore, we will validate this
discovery in FTSEC cell lines with driver mutations and patient-derived cells, and investigate the GPRC5A
molecular pathway and its components that are activated in FTSEC under shear stress stimulation, by utilizing
gain-of-function and loss-of-function assays. Shear stressed and static control mutated fallopian tube cells will
be tested for stemness and the capacity to initiate tumors in immunodeficient mice. Stimulated transformed
fallopian tube cells will also be injected into immunocompromised mice to investigate the cell’s ability to colonize
and form tumors. These studies will also be performed in mice with intact immune systems in order to assess
whether immune cells impact growth and dissemination. Given that no published studies have yet identified the
role of shear stresses in dissemination of early precursor lesions in ovarian cancers, the proposed work can
potentially have much broader impact. For example, with our dynamic microfluidic and 3D bioreactor models,
mechanotransduction and immunotherapy drugs can be screened for development of effective cancer therapies.
The components of the shear stress-induced mechanotransduction that are identified in our proposed work,
could also be utilized in early detection of ovarian cancers. As a result, the important role of shear stresses in
the fluidic niches of ovarian cancers will be established. Lastly, our study on the mechanical regulation of
transformed epithelial cells will be highly relevant to fundamental biology and clinical translational alike.

Public health relevance
PROJECT NARRATIVE Many high-grade serous ovarian cancers originate from the fallopian tubes, from where the shedding of transformed fallopian tube secretory cells leads to metastasis. In this work, we will investigate if the fluidic environment around transformed fallopian tube cells has any roles in their release within the peritoneal organs. With the in vitro and in vivo models developed in our labs, we will establish the importance of shear stresses in the fluidic niches of fallopian tubes, that could be utilized in early detection of ovarian cancers.